REACH Center Exposure Assessment Core

PROJECT SUMMARY - EXPOSURE ASSESSMENT CORE
The REACH Center Exposure Assessment Core aims to provide expertise and services on big data use,
exposure assessment, and statistical analysis to support research exploring health-protective solutions
for climate-sensitive risk factors. The Core will develop unique, new services and capabilities in selecting
and using appropriate techniques and tools to assess exposure for a variety of research applications,
including epidemiology, risk analysis, burden of disease assessment, disease forecasting, and policy
analysis. Datasets and tools will include satellite remote sensing, ground stationary and mobile
monitoring, statistical and geophysical modeling, among other techniques. Specifically, the Core will
build capacity among Center investigators to identify and select appropriate geospatial
environmental datasets. To do so, the Core will empower researchers to identify important climaterelevant
hazards with screening-level mapping tools and aid researchers in selecting fit-for-purpose
geospatial datasets. The Core will also lower the barrier to using geospatial datasets in research at the
intersection of climate and health. This will be accomplished by spatially and temporally aligning
environmental data with health data, providing user guides with data descriptions and sample code, and
providing consultation services for researchers to ask questions about applying the datasets. Finally, the
Core will provide statistical support, including comprehensive statistical analysis, data usage advisory
and consultancy, and conducting statistical and collaborative research to advance beyond what is
available in the current literature. The Exposure Assessment Core will bridge the gap between novel
geospatial datasets and research on health-protective solutions by making geospatial datasets more
accessible, interoperable, and interpretable for health researchers. The Core enables the Center and the
broader community to overcome a major challenge in climate and health research: that
environmental data are often spatiotemporally mis-aligned with health data, are poorly accessible to
researchers outside of geosciences, and come with various strengths, weaknesses, and uncertainties.